Imaging Core

S-nitrosylation study will lead to a potential clinical importance in the area of asthma, cystic fibrosis, and pulmonary arterial hypertension. The participating investigators require state-of-the-art imaging methodologies to demonstrate in 3- or 4-dimension of S-nitrosothiol localization and trafficking in neuronal, endothelial and epithelial cells. As outlined below the W.M. Keck Center for Cellular Imaging (KCCI) is one of the leading centers internationally in the area of advanced molecular imaging. We have the necessary space and imaging systems to implement successfully the participating investigator projects.